PULMONARY HYPERTENSIVE DISEASES--EFFECT OF VASODILATOR ADMINSTRATION

The purpose of this study is to enhance the understanding of what vasodilators do in certain diseases with pulmonary hypertension and to predict those patients who are going to be most responsive to these agents.